Accelerating Bioengineering Approaches for Increasing Access to New Solutions Targeting Breast Cancer Reconstructive Surgery

ABSTRACT
There is a need in the market for a true platform technology that processes large volumes of
tissues. Syntr Health Technologies has dedicated the last seven years developing the technology
that can streamline tissue processing. Our FDA-cleared SyntrFuge System and SyntrFPU360, is
a platform technology that can process a variety of different tissue types such as cancer tumor
tissue by dissociating them into single cells to better understand tumor tissue heterogeneity, and
microsizing adipose tissue for breast cancer reconstructive surgery, of which the global breast
cancer reconstruction market size was $2.68 billion in 2021 and growing at a CAGR of 7.1%.
Also, our platform can be used to microsize autologous adipose tissue to be used for reinjection
back into the patient to treat medical conditions of the aging population such as diabetic foot
ulcers and knee osteoarthritis. Syntr successfully completed an SBIR Phase I grant where we
utilized micronized adipose tissue to heal diabetic ulcers in an animal model. This study had an
important role in developing a treatment modality that clinically translated successfully into
humans. Preliminary human clinical data shows complete diabetic foot ulcer wound closure within
3-5 weeks using autologous adipose tissue processed in the SyntrFuge System.
Our platform technology for the rapid processing and/or microsizing of tissues can disrupt these
markets in a major way. The seamless large volume processing of tissues using this technology
in this Phase I SBIR is paramount to increase favorability in the adoption of this much needed
technology in various medical fields.

Public health relevance
Project Narrative This project will be increasing the tissue processing capacity of an FDA-cleared system for microsizing autologous adipose tissue for the use in regenerative medicine such as breast cancer reconstructive surgery. This project will provide a valuable role in developing an array of tissue processing capacities and parameters within an automated system for the use in multiple medical procedures in the regenerative medicine field.